Metabolic Regulation in the Pathophysiology of Disease

The role of perturbations in mitochondrial function and in cellular nutrient handling is important in the development and progression of diabetes. Candidate proteins identified that may modulate the nutrient handling and mitochondrial regulatory progrmas in diabetes and nutrient overload have been identified and these are being characterized via functional genomics to evaluate their role in the development of metabolic perturbations and mitochondrial dysfunction in diabetes and obesity. The proteins that are being investigated modulate mitochondrial biology via the modification of lysine residues of mitochondrial proteins the target regulatory proteins modulating these post-translational modifications being explored include acetyl-transferases, deacetylases and ubiquitin ligases. Emerging work suggests an interaction between endoplasmic reticulum control of calcium and mitochondrial biology. This link is being explored in the context of the regulatory role of GCN5L1 - a protein identified in the laboratory.

Additional work on this project explores the role of GCN5L1/BLOC1S1 on endosome-lysosome biology as an added role in nutrient sensing and intracellular quality control.